Mentored Enhanced Implementation and Evaluation of National VA Mandates To Prevent The Spread Of C Difficile infection

Background: C. difficile infection (CDI) is increasing in incidence and severity; CDI affects 500,000 Americans
each year, causes 20,000 deaths annually, and imposes a significant financial burden on healthcare
institutions. Preventing CDI is essential, and the VA Multidrug Resistant Organism (MDRO) Program Office
recently mandated a bundle for prevention of CDI in VA facilities. The bundle includes appropriate diagnostic
testing, optimization of hand hygiene compliance, contact isolation for CDI, and environmental cleaning of
rooms of patients with CDI. However, it does not address optimum implementation strategies to ensure
successful application of these interventions, nor does it prescribe how these measures may be undertaken.
Implementing and adhering to these recommended measures varies considerably across institutions.
Specific Aims: The central hypothesis of this project is that variation in practices and approaches related to
environmental cleaning—particularly daily cleaning—will emerge as major contributors to variable
implementation of the CDI bundle and CDI rates. The rationale stems from the literature identifying frequent
environmental contamination with C. difficile and the findings of our pilot work. Our objective is to assess work
system barriers and facilitators to bundle implementation using a mixed-methods approach. The specific aims
for this project are:
1. To evaluate the association between existing CDI bundle implementation and CDI rates at 10 VA sites.
2. To identify practices that facilitate or impede CDI bundle implementation at 10 VA sites.
3. Pilot and finalize tools to improve environmental cleaning at one VA site using the rapid plan-do-study-
act cycle methodology of quality improvement.
Methods: We will use the innovative Systems Engineering Initiative for Patient Safety (SEIPS) 2.0 model of
work system and patient safety as the study framework integrated with the iPARiHS framework. This model, as
well as general literature on guideline implementation, will guide interview questions. Participants will include
nurses, physicians, patients, environmental services and hospital leadership. We will conduct direct
observations of healthcare workers based on the SEIPS 2.0 model. We will observe patient rooms, individuals,
tasks, and organization to better understand the overall work system that surrounds the process of care for
CDI patients.
Impact: Prevention of Clostridium difficile is a priority of the VA, and implementation of a C. difficile prevention
bundle, akin to an already established methicillin-resistant Staphylococcus aureus (MRSA) bundle, has
recently been rolled out nationally. However, our ability to devise and implement strategies for containment of
C. difficile is hampered by a limited understanding of factors influencing acquisition, spread, and prevention of
C. difficile in VA facilities. Immediate benefits of achieving the objectives of this proposal will be generation of
important data regarding barriers and facilitators of implementation using a systems engineering approach.
Our study will produce data, methods, and tools that have widespread relevance and portability, with the
potential to reduce healthcare-associated infections (HAIs) including but not limited to C. difficile infection.
This is the first research study to systematically examine barriers and facilitators of implementation of a
prevention bundle for CDI. Our project is innovative in that it will employ the SEIPS 2.0 framework to undertake
a complete work systems analysis for CDI prevention; use a number of complementary approaches to data
collection; and consider not just healthcare workers involved in direct patient care, but also ancillary staff who
are critical to successful CDI prevention. Our study methods and approach may be widely used not just for CDI
but also other HAIs, and will add to the fields of patient safety and infection control.

Public health relevance
Clostridium difficile is a pathogen that causes serious healthcare-associated diarrheal illness in veterans. Prevention of healthcare facility-onset of C. difficile infection (CDI) is essential. However, there is limited data on the barriers and facilitators of implementation of preventive measures for CDI in VA facilities. The VA has recently mandated a national CDI prevention bundle, which includes rapid diagnosis of CDI, isolation of patients with CDI, environmental disinfection, and optimization of hand hygiene. However, the method of implementation of the specific elements of the bundle is variable across facilities. The work proposed will examine barriers and facilitators to implementation of the CDI bundle using a blend of an innovative Systems Engineering Initiative for Patient Safety (SEIPS) 2.0 framework and the iPARiHS model. We will undertake a mixed-methods study, the results of which will inform implementation of infection control measures for CDI prevention throughout the VA.